DIGITAL INTRAVENOUS ANGIOGRAPHY AND RENOVASCULAR HYPERTENSION

This study intends to determine the value of digital intravenous angiography in diagnosisn g renovascular hypertension. The latter will be determined by measurement of PRA and aldosterone and responses to saralasin under controlled conditions and results compared with observations made by DIVA, renal scans, and timed IVP's.